Discovering Novel Mechanisms and Treatment for Aging-Related Dementia: Probing Medin and Abeta Vasculopathy

Abstract
Vascular dementia (VaD) is the second most common cause of dementia overall and the most common
in patients < 74 years old. In an aging veteran population, dementia is a critical health care issue that affects
7.3% of veterans ≥ 65 years old1. To prevent or manage VaD, it is critical to understand its early pathophysiology,
specifically learning how vascular disease and inflammation, a process that occurs decades before VaD,
modulate neuroinflammation and neurodegeneration. We have identified and characterized a novel putative
agent for vascular aging, medin, one of the most common human amyloid proteins, found in greater quantities
in VaD and Alzheimer's disease (AD) patients, and which can cause endothelial dysfunction, pro-inflammatory
activation similar to cardiovascular risk factors (CVRFs), as well as exacerbate hypoxic injury to endothelial cells
(ECs). In later stages of vascular disease, atherosclerotic and thromboembolic changes can lead to ischemia
and brain tissue hypoxia or stroke, the 5th major cause of mortality. Investigating factors, such as medin, that
could potentially exacerbate this injury would lead to new treatment targets. Additionally, we showed that
monosialoganglioside-containing nanoliposomes (NLGM1, phospholipid particles <100 nm) protect against
hypoxia and oxidative stress-induced endothelial dysfunction and vascular inflammation. Based on these initial
discoveries, our overall goal is to investigate how the aging vasculature influences neural inflammation and
function and identify novel treatment targets and intervention to mitigate hypoxic injury in VaD. In Aim 1 we will
establish mechanisms by which cerebrovascular inflammation modulates neuroinflammation and
neurodegeneration. Here we will use 2D cell, novel 3D vascularized brain organ-on-a-chip and isolated ex-vivo
collateral cerebral arteries from brain donors with VaD, AD or normal cognition to determine how vascular
inflammation induced by medin or CVRFs modulate astrocyte and microglial inflammation and affect neuronal
function and viability. In Aim 2, we will establish the role of medin in modulating hypoxic neurovascular unit
injury. We will also test whether NLGM1 could protect against hypoxic injury to cellular components of the
neurovascular unit using the 3D chip model and perform pilot investigation to test whether NLGM1 can protect
mice against hypoxic injury from middle cerebral artery occlusion. Using novel cellular and human tissue models
developed by our group, the proposal could impact our fundamental understanding of the early genesis of VaD,
identify and characterize medin as a novel treatment target and validate NLGM1 as a novel therapeutic option.

Public health relevance
Project Narrative Vascular dementia (VaD) is a condition that arises from development of cerebrovascular disease leading to decreased flow to the brain that causes degeneration and inflammation of brain tissue. It is the second most common cause of dementia overall and an important clinical problem among veterans and the general public. To prevent or manage VaD, we need better understanding of its early development, identify factors that exacerbate the condition and develop new ways of treatment. The goal of this proposal is to investigate how the aging blood vessel, characterized by inflammation caused by agents such as medin (a protein that accumulates with aging) as well as cardiovascular risk factors (increased lipid and glucose), could lead to inflammation and degeneration of brain cells and test a novel treatment agent, monosialoganglioside nanoliposome, to protect brain cells against hypoxic injury. The proposal could impact our fundamental understanding of the genesis of VaD and identify new molecular targets and treatment interventions to prevent or control the disease.